Cultural Consensus Modeling to Identify Culturally Relevant Risk and Protective Factors for Suicide among Sexual Minority Youth

ABSTRACT
Sexual minority youth report significantly higher rates of past year suicidal ideation (19.4%-30.3%) and suicide
attempts (6.6%-22.7%), as compared with heterosexual students (9.3% and 3.8%, respectively). Theoretical
models of suicide and the interventions they inform have been developed with limited representation of sexual
minority populations, thereby limiting their relevance for sexual minority youth. We will be the first to make use
of a rigorous, multi-method, ethnographic approach, called Cultural Consensus Modeling (CCM), to leverage
rich qualitative data on sexual minority youth (ages 15-25 years) and their motivations for suicide, to develop
models and assessment tools generated specifically from these motivations. We will then evaluate cultural
models for their association with more traditional suicide predictors derived from IPTS (perceived
burdensomeness, thwarted belongingness, acquired capability). Guided by a conceptual framework that
integrates the interpersonal-psychological theory of suicide (IPTS) and minority stress theory, our central
hypothesis is that derived cultural models will point to the importance of redefining IPTS variables through the
lens of minority stress. The CCM methodology is iterative in nature with initial study phases informing
subsequent phases, verifying and further testing derived cultural models. Aim 1 will recruit 50 sexual minority
youth (ages 15-25 years) with a past-year history of suicidal ideation. Making use of “free listing” CCM
methodology, youth will be asked to identify risk factors (common reasons) for suicidal thoughts and behaviors
among peer sexual minority youth. We hypothesize that sexual minority youth will generate IPTS-related
motivations for suicide as well as motivations related to minority stress. Aim 2 will recruit a new sample of 100
at-risk sexual minority youth who will rate the culture-relevance of factors generated in Aim 1 on a 5-point
Likert scale. This process identifies unique clusters of individuals (cultural consensus models) who place
greater importance on particular factors and we hypothesize that more than one cultural consensus model will
emerge. Aim 3 will utilize a subset of participants (N=30) who completed Aim 2 to represent each identified
cultural model. Qualitative interviews will be conducted to gather in-depth information on each cultural model.
Informed by the results of Aims 1-3, Aim 4 will recruit a new sample of 200 at-risk sexual minority youth,
alongside measures of IPTS and minority stress/discrimination to test the hypotheses that (1) cultural models
will map well onto own reasons for suicidal thoughts and behaviors; (2) cultural models will align with individual
differences in IPTS and minority stress/discrimination, and that (3) models that align with minority
stress/discrimination will most strongly predict suicide severity, pointing to the importance of redefining IPTS
variables through the lens of minority stress theory. The proposed work responds to urgent calls for research
on the risk factors for suicidal behaviors in sexual minority youth and will, for the first time, provide empirically
derived treatment targets for culturally relevant treatment adaptation of suicide prevention programs

Public health relevance
PROJECT NARRATIVE The perspectives of sexual minority youth are vastly underrepresented in extant theories, research, treatment development for suicide prevention, particularly considering the substantially elevated rate of suicidal thoughts and behaviors in sexual minority populations. Failure to incorporate the voices and lived experiences of sexual minority youth perpetuates health disparities, underutilization of treatment, and treatment dropout among sexual minority youth. Using a rigorous, ethnographic approach called Cultural Consensus Modeling, this project will provide an empirically-based multi-method model of the shared cultural determinants of suicidal thoughts and behaviors among sexual minority youth, as perceived by sexual minority youth themselves, to inform culturally relevant treatment targets and provide clear recommendations for adapting theoretical models of suicide to address the needs of sexual minority youth.